DNA Replication and Cytokinesis.

This is an application for the Administrative Supplement to the currently active R35GM148158 grant entitled
“DNA replication and cytokinesis”. The major thrust of the parent grant is to understand the functions of
replication initiators Orc6 and ORC in eukaryotic cells and tissues using Drosophila and human cells as model
systems. ORC, heteromeric six-subunit protein complex, is essential for DNA replication. The smallest of ORC
subunits, Orc6 protein, is important for DNA replication in all eukaryotes. We have shown that in Drosophila Orc6
has an additional role in cytokinesis through interaction with the septin complex, a highly conserved polymerizing
protein assembly that is critical for cytokinesis in many species and is recognized as important component of the
cytoskeleton. In preliminary studies we have identified structural features of Orc6 that contribute directly to the
functions of the protein in replication and cytokinesis. The overall goal of this proposal is to define the distinct
mechanisms of Orc6 function in DNA replication and in cytokinesis using Drosophila as a model system. All
major objectives of the parent grant require constant purification of the wild type and mutant protein complexes
(such as ORC and septin complex and their subunits) to study protein functions and protein/DNA interactions.
The Synergy H1 multi-mode microplate reader is conceived for ease-of-use and flexibility and ensures effortless
detection setup for simplified data generation. Equipped with Variable bandwidth monochromator fluorescence,
Monochromator absorbance, Full-light luminescence and Time resolved fluorescence, it can cover a wide range
of applications in basic research and life science. The Administrative Supplement will allow us to purchase a
new Synergy H1 that will greatly facilitate and advance our studies and workflow. The purchase of new
equipment required for the project and associated research expenses will provide the necessary investment into
the research-oriented economy. We believe that the discoveries made with the help of the new Synergy H1
system funded by the Administrative Supplement will significantly strengthen our chances for obtaining future
NIH support through competitive renewal application. This in turn will ensure preservation of the newly created
and current research positions supported by the parent grant.

Public health relevance
This is an application for the Administrative Supplement to the currently active R35GM148158 grant entitled “DNA replication and cytokinesis”. The Administrative Supplement will allow us to purchase a new Synergy H1 plate reader that will greatly facilitate and advance our studies and workflow. The purchase of new equipment required for the project and associated research expenses will provide the necessary investment into the research-oriented economy.